Trends of disparities in breast cancer progression and health care considering multilevel risk factors

A Scalable Cloud-based Platform for Multiple Mediation Analysis
The primary objective of the parent award (#MD012387-02) is to examine the trend of racial
disparity in the use of Oncotype diagnosis among breast cancer patients. It also aims to monitor
how social and physical environments, as well as individual behaviors, contribute to the racial
disparities in breast cancer outcomes. To achieve these goals, the parent award focuses on
developing novel mediation and moderation analysis methods using state-of-the-art machine
learning algorithms and software. These methods can help identify and differentiate risk factors
that explain health disparities and their changes over time, considering the potential nonlinear
associations and complicated interaction effects involved.
As part of the parent award, an R package mma has been generated for the newly developed
method. The goal of this administrative supplement proposal is to expand the use of mma by
collaborating with a software engineer in two ways. Firstly, build an interactive visual interface
with drag-and-drop functionalities to enable users who are not familiar with the R language to
take advantage of the R package. Secondly, refactor the mma functions to enable the use of
parallel computing and GPU support in the cloud high-performance computing environment.
In summary, the proposal seeks to make the advanced technology accessible and promote the
widespread adoption of the novel mediation and moderation method among researchers.

Public health relevance
Project Narrative We are developing a GUI and refactoring an R package for mediation analysis for public health researchers and practitioners. The mediation analysis software can contribute to public health by helping researchers and practitioners to better understand the complex mechanisms through which different factors influence health outcomes. This knowledge can inform the development of more effective interventions and policies to improve public health.